Clinical and Translational Sciences Core

PROJECT SUMMARY (See instructions); The Clinical and Translational Sciences Core (CTSC; Core C) will provide key services to UR investigators to promote collaborative clinical and translational HIV/AIDS research. The objective of the Core is to efficiently provide UR HIV/AIDS investigators direct access to human subjects research, a discipline that can be dauntingly complex and time-consuming for new investigators (including early-stage investigators, investigators new to HIV/AIDS, and basic science HIV/AIDS investigators wishing to conduct translational research). It will do so by leveraging existing infrastructure, resources and expertise, at modest incremental cost, to create broad synergies that can make a major impact on clinical and translational studies. Our experience as a D-CFAR has shown that providing that access to services alone is not necessarily sufficient to encourage new investigators to undertake translational HIV/AIDS projects. This has led us to develop a highly proactive, user-oriented, innovative approach, that includes consultation, advice and even identification and recruitment of study subjects (

Public health relevance
RELEVANCE (See instructions): The Clinical and Translational Sciences Core (CTSC; Core C) will help CFAR investigators conduct